Epigenetic Control of Nephron Progenitor Cell Lifespan

SUMMARY
In mice and humans, nephrogenesis ceases perinatally and so is the opportunity to generate new nephrons
following congenital or acquired loss of renal mass. A significant barrier to progress in the renal regeneration
field is insufficient knowledge surrounding the mechanisms driving cessation of nephrogenesis. Recent genetic
and epigenetic evidence support the notion that the lifespan of nephron progenitor cells (NPCs) is not fixed. The
mechanisms whereby perinatal NPCs cease to self-renew and exhibit distinct metabolic fuel requirement and
enhanced responsiveness to differentiation factors are under intense investigations. Initial comparative analysis
of the chromatin landscape and gene expression at single-cell resolution has unraveled age-dependent
chromatin remodeling affecting the accessibility of candidate cis-regulatory elements (cCREs), thus implicating
epigenetic mechanisms in NPC age. The current proposal is designed to test the overall hypothesis that age-
related redistribution of transcription factor-binding sites (TFBS) decommissions cell identity/renewal cCREs and
engages AP-1-linked chromatin triggering the NPC differentiation program. We further propose that maintenance
of the bivalent chromatin state by H3K27 methylation restrains AP-1-linked chromatin activity and can potentially
be exploited to maintain NPC stemness. We present a comprehensive experimental design that combines
cutting-edge multiomics, epigenomics, and mouse genetics to dissect the complex regulation of NPC lifespan.
Aim 1 will test the hypothesis that redistribution of TFBS from cell identity to AP-1-linked cCREs underpins
chromatin remodeling in NPC age. Leveraging deep multiome profiling, we will uncover TF/TFBS pairs affected
by age-related chromatin remodeling. CUT&RUN will elucidate the AP-1 TF subunit(s) that physically occupy
differentially accessible cCREs. Preliminary evidence implicates the transcription factor ATF4. Aim 2 will test
the hypothesis that age-related enrichment in ATF4/TFBS drives NPC differentiation. Conditional gain and loss
of function approaches will establish the necessity and sufficiency of ATF4 in driving NPC differentiation. This
will be followed by mapping the ATF4-dependent regulome and downstream gene-regulatory networks. Aim 3
will test the hypothesis that histone bivalency controls NPC lifespan by restraining AP-1 activity. We will first
demonstrate that resolution of bivalent chromatin in perinatal cCREs is mediated by the H3K27 demethylase,
Kdm6b. Next, we will demonstrate that maintenance of chromatin bivalency in vivo, via Kdm6b inactivation,
closes AP-1-linked cCREs and sustains NPC lifespan. Lastly, we will demonstrate that targeted closure of AP-
1 TFBS in cultured NPCs by epigenome editing maintains NPC stemness.
Successful completion of this project will have broad impacts on defining the rules of epigenetic control of
nephron progenitor maintenance. This knowledge may be translated to optimizing nephron regeneration and
understanding epigenetic programming of renal disease.

Public health relevance
NARRATIVE In mice and humans, generation of new kidney filters (nephrons) ceases around the time of birth and so is the opportunity to generate new nephrons following congenital or acquired loss of kidney function. Therefore, understanding why nephron progenitors (stem cells) cease to self-renew is paramount to developing new regenerative therapies. This proposal aims to define how genes are instructed to alter their activity at the end of nephrogenesis and thus determine the lifespan of nephron progenitors. This knowledge may be translated to optimizing kidney regeneration protocols and understanding causes of congenital kidney disease.